Enhancement of neural regeneration

Project Summary/Abstract
Organisms with regenerative abilities have been informative models for uncovering natural mechanisms by
which nervous system damage activates stem or progenitor cells for injury repair. The timing, location, and
extent of injuries are not predetermined, requiring the existence of mechanisms that instruct tissue restoration
activities that perfectly counter the effects of damage. A key question to understand this process is how
cessation of regenerative growth is accomplished. To begin to address this question, it is essential to define
the transcriptional and cell signaling systems that negatively regulate adult regenerative neurogenesis. While
regenerative tissues have been extensively probed for positive regulators of regeneration, much less is known
about factors that act in opposition and whose inhibition could lead to enhanced neural regeneration. In the
aims of this grant, this deficit is addressed by leveraging expertise in the planarian system, which uniquely
allows access to the biology of complete adult brain regeneration. Uncovering the conserved and fundamental
mechanisms used by organisms to limit the extent and rate of tissue regeneration and cell turnover will provide
foundational insights into understanding and ultimately treating diseases characterized by an inability to
undergo sufficient neural repair.

Public health relevance
Project Narrative Organisms capable of tissue regeneration after injury offer natural biological solutions to the problem of how stem cell activities can be controlled to repair damaged organs. In particular, such organisms must have mechanisms to ultimately cease regenerative outgrowth in order to precisely restore damaged tissue. The goal of the proposed project is to identify conserved molecular targets that normally act to limit adult neural regeneration and to elucidate the primary mechanisms by which neural regenerative capacity could be enhanced.